Biomaterials for delivery and maintenance of tip endothelial cells

PROJECT SUMMARY
The mortality rates for patients with critical limb ischemia (CLI) are 15-40%, depending on the treatment.
Moreover, the quality of life for surviving patients remains severely reduced. Limb revascularization focused on
limb rescue is critical to saving lives and life quality. Cell therapy strategies currently under investigation inject a
variety of progenitor cells into ischemic tissue with varying levels of success. However, no one has examined
the ability of angiogenic tip-specific endothelial cells (ECs) to promote revascularization in an ischemic limb. We
hypothesize that angiogenic ECs that contain tip ECs will more robustly revascularize ischemic limbs compared
with nonangiogenic ECs. The proposed studies will use highly expandable pluripotent stem cells as the starting
cell source and derive tip and non-tip cell-containing ECs from human induced pluripotent stem (iPS) cells. We
will then compare the ability of tip ECs versus non-tip ECs to rescue the muscle in a hind-limb ischemic mouse
model. For delivery, we employ spatially nanopatterned collagen biomaterial scaffolds to enhance cell survival
after transplantation into the ischemic limb. Lastly, we will incorporate placental growth factor (PIGF) mRNA
delivery from aligned nanopatterned collagen biomaterials to support the release of PlGF protein for maintaining
the angiogenic phenotype of tip ECs, and/or directing in vivo the differentiation of stalk-to-tip ECs. We expect
these studies to show that angiogenic tip-specific ECs, not only integrate into and support current vasculature in
the ischemic limb, but also initiate the growth of new blood vessels, faster re-establishment of tissue perfusion,
and reproducibly rescue the ischemic limb.

Public health relevance
PROJECT NARRATIVE Patients with critical limb ischemia (CLI) patients continue to suffer from severely reduced quality of life and high mortality rates with revascularization remaining an important first line of treatment. Clinical trials of revascularization procedures and medical therapies, like angioplasty or bypass surgery, are associated with some improvement in subsequent amputation-free survival by about 6 months, but the quality of life assessments remain extremely low compared with normal population values. The proposed studies will deliver tip-specific endothelial cells (ECs) derived from pluripotent stem cells to direct the growth of new blood vessels in murine ischemic hind limbs to address this unmet need for patients with CLI.